Regulation of Liver Regeneration by UHRF1

Project Summary
The remarkable regenerative potential of the liver in young mammals is due to the ability of quiescent
hepatocytes to nimbly respond to mitogenic signals. This relies on a well-coordinated gene regulatory
program, which we propose is embedded in the hepatic epigenome. The epigenome serves dual roles in
regulating gene expression and in protecting cells from the threat of transposable elements (TEs), which if
unleashed can cause DNA damage and genomic instability. A complex combination of epigenetic marks
organizes the genome into regions (i.e. chromatin states) which dictate which regions stay open and which
stay closed. Closed chromatin states encompass silenced genes and most TEs. Open chromatin states
contain actively transcribed genes as well as genes held in a poised configuration in anticipation of signals
that alter their expression to change cellular function or identity. We discovered that genes that promote
liver regeneration are poised in quiescent livers, with repressive (H3K27me3) and activating (H3K4me3)
marks. Since H3K27me3 was lost on these genes during regeneration, we conclude this is a key element of
the epigenetic code that confers regenerative potential to young livers. We uncovered a surprising flexibility
in this code through studying the epigenetic regulator, UHRF1, which is essential for maintaining DNA
methylation during DNA replication. We found that Uhrf1 loss in hepatocytes (Uhrf1HepKO) resulted in global
DNA hypomethylation, but did not activate TEs. We attributed this to epigenetic compensation by
H3K27me3, which became enriched on hypomethylated TEs and depleted from promoters in Uhrf1HepKO
mice, with a concomitant premature activation of pro-regenerative genes and accelerated liver regeneration
in these mice. Our central hypothesis is that the youthful epigenetic code permits transcription factor
access to pro-regenerative genes while restricting access to TEs, and that this code is rewritten
during aging, resulting in TE activation and regenerative decline. We further hypothesize that UHRF1 and
H3K27me3 are key elements of this code. To test this, we will identify the molecular mechanisms of
epigenetic compensation in young Uhrf1HepKO livers and will examine the role of H3K27me3 in pro-
regenerative genes regulation in wild type livers (Aim 1). By Integrating epigenomic and transcriptomic
profiling of aged mouse and human livers compared to chromatin states in young livers, we will establish
how aging repatterns the hepatic epigenome to repress pro-regenerative genes and activate TEs (Aim 2).
In Aim 3, we explore whether depleting H3K27me3 can rejuvenate the liver. Together, the outcomes of this
work will uncover how the dual roles of the epigenome – gene regulation and suppression of transposon
threat – are integrated in regulating liver regeneration in young mice and will provide a foundation to
manipulate the epigenome to augment regenerative potential in the elderly and those suffering from liver
failure.

Public health relevance
No change Modified Specific Aims The remarkable regenerative potential of the liver in young mammals is due to the ability of quiescent hepatocytes to nimbly respond to mitogenic signals. This potential is attributed to the coordinated regulation of genes that drive proliferation. We [1, 2] and others [3] demonstrated that this transcriptional response is governed by a hepatic epigenetic code characterized by bivalent marks on pro-regenerative genes and that there is a repressive code on transposable elements (TEs). Our central hypothesis is that the youthful epigenetic code permits transcription factor access to pro-regenerative genes while restricting access to TEs, and that this code is rewritten during aging, resulting in TE activation, parainflammation [4, 5] and regenerative decline [6-8]. To test this, we will establish which elements of the code are critical for regeneration and TE suppression in young animals, determine the mechanism by which these elements compensate for each other in response to epigenome repatterning, and will then define how this code changes during aging. Using a machine learning approach on multi-omic datasets, we defined the relationship between the chromatin states that comprise the epigenomic landscape in young, quiescent mouse livers and the expression of genes and TEs both in quiescent and regenerating livers following partial hepatectomy (PH) [2]. As expected, TEs are silent, and reside in closed chromatin states, while highly expressed genes fundamental to liver function reside in open states. Surprisingly, open chromatin states also contained thousands of genes that were silent in quiescent livers, including pro-regenerative, E2F target genes. We found that these genes were bivalently marked with active (H3K4me3) and repressive (H3K27me3) modifications in quiescent livers, and, strikingly, that H3K27me3 was depleted from their promoters following PH, concomitant with their activation. This suggests that H3K27me3 is a key element of the epigenetic code that confers regenerative potential to the liver. This is supported by our finding that hepatocyte specific knockout of a key DNA methylation factor, Uhrf1 (Uhrf1HepKO) results in the repatterning of H3K27me3, so that it is depleted from promoters of E2F target genes and enriched on hypomethylated TEs in a process we termed epigenetic compensation. The result is that Uhrf1HepKO mice show premature and sustained activation of pro-regenerative genes and enhanced liver regeneration following PH [1]. We will use a combination of genomic and functional approaches to investigate the role of H3K27me3 in gene and TE regulation in quiescent and regenerating livers and in epigenetic compensation. This will advance the important goal of understanding how the young liver epigenome sustains liver regeneration and suppresses transposon threat, which could be leveraged to develop therapeutic interventions to sustain liver health. The loss of regeneration capacity in the aged liver [12-17]. is accompanied by widespread epigenetic changes, TE activation and inflammation [9-11]. We hypothesize that these are linked due to shifting of pro-regenerative genes to repressive chromatin states and TEs to active ones. The finding that young animals with constitutive H3K27me3 depletion in hepatocytes develop some of these phenotypes found in older animals [18-20], combined with our hypothesis that H3K27me3 is a key element in the hepatic epigenetic code in young animals, suggests that this mark as a regulator of the hepatic healthspan. We will test the exciting possibility that promoting epigenetic compensation in aged livers could rejuvenate them by facilitating activation of pro-regenerative genes. If successful, this could guide development of therapies to augment regeneration in elderly patients and those suffering from liver failure. specific aims, we will to uncover fundamental mechanisms about how the epigenome regulates genes, TEs and regeneration in the liver throughout the lifespan: Aim 1. Determine the role of H3K27me3 and Uhrf1 in setting the epigenetic code in young livers. Hypothesis: Epigenetic compensation in Uhrf1HepKO livers shifts H3K27me3 from promoters to suppress TEs. NEW Approaches: In Uhrf1HepKO and WT mouse livers, we will: 1A. Profile genome occupancy of E2F1 and EZH2; and 1B. Deplete H3K27me3 from hepatocytes using pharmacological and genetic approaches and evaluate the effects on TE and gene expression in quiescent and regenerating livers. Aim 2. Decipher how aging rewrites the hepatic epigenetic code. Hypothesis: Pro-regenerative genes shift to repressed chromatin states and TEs to active states in aged livers. NEW Approach: Using publicly available epigenomic data, define chromatin state and transcriptomics of aged human and mouse livers and determine how these changes relate to regeneration component in young livers. Aim 3. Determine if epigenetic compensation can rejuvenate the liver. Hypothesis: Epigenetic compensation induced in young mice can extend the youthful epigenetic code to prevent TE expression, parainflammation and enhance liver regeneration during aging. Approach: Induce epigenetic compensation in young mice by constitutive Uhrf1HepKO and inducible H3K27me3 depletion and, when these animals age, assess changes in TE and gene expression and liver regeneration.